Sleep apnea treatment and risk for cognitive decline and Alzheimers disease

ABSTRACT
The prevalence of Alzheimer’s disease and related dementias (ADRD) is expected to increase four-fold by 2050.
Consequently, there are efforts to identify “actionable” risk factors, that if identified and addressed early, have
the potential to prevent cognitive decline and onset of ADRD. Obstructive sleep apnea (OSA) is associated with
risk of cognitive decline and ADRD, particularly among older adults. As effective treatments are available for the
condition (e.g., Continuous Positive Airway Pressure [CPAP]) that are demonstrated to be highly efficacious
when used adherently, OSA may be an ideal target for ADRD risk reduction. In this study, we propose to
characterize associations between OSA treatment (specifically CPAP) and cognitive decline and ADRD over up
to 14 years of follow-up (2010-2024) in two nationally representative NIA-funded cohorts of U.S. older adults:
the Health and Retirement Study (HRS), and National Health and Aging Trends Study (NHATS). We also intend
to determine whether the effects of OSA treatment on cognition differ in those at higher risk for ADRD (e.g.,
minority race/ethnicity, advanced age, cardiovascular risk factors/disease, etc.) in order to identify populations
among whom treatment is most likely to yield effects and ways OSA treatments could be optimized in groups
not benefiting. Both HRS and NHATS include nationally representative samples, have repeated performance-
based cognitive measures to characterize cognitive performance trajectories and ADRD, and linkages to
Medicare claims for ascertainment of OSA diagnosis and treatment. The study will use innovative methods to
harmonize datasets and will address three specific aims. Aim 1 will be to determine the association of OSA with
cognitive trajectories and incident ADRD from 2010-2024, and examine whether OSA interacts with other ADRD
risk factors with regard to cognitive decline and ADRD risk. Aim 2 will be to determine, among individuals with
OSA, whether CPAP is associated with better cognitive outcomes from 2010-2024. Specifically, we will examine
whether a) receipt of CPAP (compared to no treatment) is associated with slower cognitive decline and lower
risk for ADRD, b) among those treated whether initiation of CPAP is associated with a slowing of cognitive decline
and lower risk for ADRD before and after initiation, and c) whether these associations vary across levels of CPAP
adherence. Finally, Aim 3 will examine whether associations found in Aim 2 will differ across known ADRD risk
factors. If we find that addressing OSA is particularly effective in slowing cognitive decline/preventing ADRD,
especially in high-risk groups, then our study’s results will help us understand the means by which OSA can be
treated in the population and contribute to development of programs to treat OSA in these populations at greatest
risk. Further, it will inform efforts to curb the burden of ADRD in the U.S. and contribute substantially to dementia
prevention efforts.

Public health relevance
PROJECT NARRATIVE This study will characterize the association between obstructive sleep apnea (OSA) and its treatment with cognitive decline and development of Alzheimer’s disease and related dementias (ADRD), and identify if these associations interact with other ADRD risk factors (e.g., cardiovascular disease) with regards to cognitive outcomes. The project will harmonize data from two long-running NIA-funded nationally representative cohort studies: the Health and Retirement Study (HRS) and the National Health and Aging Trends Study (NHATS), and will link these data to Medicare claims. Results from this study have the potential to a) identify how treatment of OSA may be a preventive measure for ADRD, and b) inform allocation of treatments to high-risk groups in order to promote preserved cognitive health in later life.